Impact of Zika Virus Infection on Fetal Innate and Adaptive Immunity

PROJECT SUMMARY
The objective of this proposal is to define the impact of maternal viral infections and inflammation on immune
programming within the fetal brain and lymphoid organs in a well-defined non-human primate (NHP) model.
Discoveries in fetal human immunology have primarily come from human cord blood with few studies of fetal
blood or the innate immune capacity of major organs. The link between innate immune activation and fetal brain
injury is unknown but is of major translational significance to guide novel therapies for fetal protection. Our
central hypothesis is that the fetal innate immune programming induced by a maternal ZIKV infection or
other infectious triggers initiates a program of cellular stress-response in the fetal brain. This connection
between the fetal immune programming and cellular stress-response pathways in the fetal brain has never been
studied across gestation or with a suite of diverse and highly sophisticated immunologic tools and platforms. Our
preliminary studies in a microculture ex vivo model using human fetal tissues demonstrate active regulation of
the innate immune response by Sendai virus (SeV; a model virus inducing innate immune activation) and Zika
virus (ZIKV) by 24 hours post-infection. Our preliminary data reveals that 3 days after a maternal ZIKV infection
in our NHP model, there is a strong correlation in the fetal brain linking the innate immune response with induction
of cellular stress and autophagy. In this proposal, we will use the NHP model to obtain a complete collection of
fetal blood and major tissues from the first and third trimesters to interrogate maturation of fetal innate and
adaptive immune programming in the fetal brain and major lymphoid organs, which we will link to cellular stress
in the fetal brain. In Aim 1, we will use an ex vivo microculture model to determine innate immune pathways
activated by model viruses (ZIKV, SeV), Type I IFN (IFN-β), IL-6 and TNF-α in the first and third trimesters within
NHP fetal brain and lymphoid organs (fetal brain, placenta, spleen, thymus, blood). In Aim 2, we will use a
pregnant NHP model of an acute ZIKV infection to link the profile of fetal innate and adaptive immune activation
with production of alarmins and induction of the autophagic response in the fetal brain. In both Aims, we will
employ diverse immunologic tools (CyTOF, Nanostring nCounter, Luminex, ELISA, immunohistochemistry, bulk
and single cell RNA-Seq) producing high-dimensional data that can be leveraged using bioinformatics to reveal
gene networks of innate immune programming that direct viral and inflammatory injury of major fetal organs in
early and late gestation, which can inform therapeutic approaches for fetal neuroprotection in the setting of
inflammatory preterm birth or congenital viral infection.

Public health relevance
PROJECT NARRATIVE This proposal will provide the first comprehensive analysis of the early events in fetal innate and adaptive immune programming to viral infection and inflammation across gestation and how immune signaling influences cellular stress-response in the fetal brain. Creation of a fetal immune atlas in response to viral infection and inflammation will provide a critical foundation for understanding how immune signaling can be targeted by novel therapeutics for fetal neuroprotection.